Development of Tissue Engineered Tregs as a Treatment for Acute Ischemic Stroke

ABSTRACT
In the U.S., nearly 800,000 individuals experience a stroke each year, predominantly ischemic strokes. The
economic burden of stroke is staggering, with projected stroke-related medical costs in the U.S. expected to
surpass $94 billion by 2035. This underscores the urgent need for effective therapies to address this significant
public health challenge. While the potential of regulatory T cells (Tregs) in promoting stroke recovery has been
recognized, translating this promise into clinical success has been hampered by several obstacles. Traditional
Treg therapies face challenges in manufacturing, phenotypic instability, and a lack of tissue specificity. This
proposal focuses on the development of allogeneic engineered tissue Tregs (EngTregs) as a novel off-the-shelf
therapeutic approach for stroke. Overexpression of ST2, the receptor for the alarmin IL-33, enhances the ability
of EngTregs to: (i) sense and respond to tissue damage (ST2-expressing EngTregs efficiently migrate to sites
of inflammation and injury); (ii) suppress excessive inflammation (EngTregs exert potent anti-inflammatory
effects through multiple mechanisms, including direct suppression of immune cells and modulation of the
inflammatory environment); and (iii) actively participate in tissue repair (EngTregs produce growth factors and
interact with other cells to promote tissue regeneration). Overexpression of FOXP3 ensures a stable and
suppressive Treg phenotype, crucial for long-term therapeutic efficacy. A chemically induced signaling complex
(CISC) enables tunable IL-2 signaling, promoting Treg survival and function while facilitating scalable
manufacturing. These innovations culminate in a first-in-class allogeneic tissue EngTreg product with
advantages in manufacturing scalability, cost-effectiveness, and therapeutic potential compared to conventional
Treg therapies. Preliminary studies demonstrate the ability of allogeneic EngTregs to accumulate in the injured
brain and improve motor skills, sensory function, learning, and memory following ischemic injury induced in the
transient middle cerebral artery occlusion (tMCAO) mouse model of stroke. This proposal outlines three aims to
further advance the preclinical development of EngTregs for stroke: Aim 1: Evaluate the therapeutic efficacy of
EngTregs in two preclinical stroke models (permanent middle cerebral artery occlusion and photothrombosis) in
both adult and aged mice, assessing a comprehensive range of functional and histological outcomes. Aim
2: Characterize the mechanism of action and define a comprehensive in vitro profile of the human EngTreg drug
product, including assessment of cytokine sequestration, T cell suppression, macrophage polarization, and
transcriptomic analysis. Aim 3: Assess the immunotoxicity and immunogenicity of human EngTregs to ensure
clinical safety, including evaluation of cytokine release syndrome and allo-immunogenicity. Successful
completion of these aims will provide critical preclinical data supporting the clinical translation of EngTregs as a
novel and promising therapeutic strategy for stroke, addressing a significant unmet medical need.

Public health relevance
NARRATIVE This research has significant public health relevance due to the high prevalence and devastating impact of stroke, a leading cause of disability and mortality worldwide. Developing effective therapies for stroke, particularly for ischemic stroke, could substantially improve patient outcomes and reduce the burden of this condition on individuals and healthcare systems. This research, focused on a novel cell therapy approach, holds the potential to address this unmet medical need by promoting brain repair and functional recovery after stroke.